Ocular Blood Flow Imaging for Glaucoma Assessment

ABSTRACT
Glaucoma is one of the leading causes of blindness in adults worldwide. There is no single instrument that can
diagnose glaucoma in all cases requiring a combination of methods including standard automated perimetry to
assess peripheral vision, optical coherence tomography (OCT) to assess retinal nerve fiber layer (RNFL)
thinning, intraocular pressure (IOP), and fundus photography to assess the cup to disc ratio. RNFL changes are
challenging to assess in individuals with a high degree of myopia as well as in patients that have previously been
treated with laser in the eye. Ocular blood flow (OBF) information from posterior segment, as obtained by an
FDA-cleared instrument called XyCAM RI developed by us, has the potential to add insights relevant to glaucoma
status that are complementary to conventional methods. Our preliminary results have demonstrated significant
differences in OBF patterns in the optic disc and macular regions in glaucoma subjects and healthy controls. Our
present Phase II project seeks to validate the diagnostic potential of OBF metrics obtained by XyCAM RI in the
management of glaucoma through a rigorous clinical study with age-matched, race-matched, and sex-matched
controls, and specifically demonstrate the usefulness of OBF-derived measurements in assessment of glaucoma
in highly myopic patients. We also seek to develop and bring to market an enhanced multi-function fundus
camera called the XyCAM FC for clinical use. The XyCAM FC will permit practitioners to visualize fundus photos
in stereo mode to assess cup-to-disc ratio and also OBF information including the most diagnostically relevant
features. As a frontier technology that complements color fundus images with video data on OBF dynamics at a
high temporal resolution, the XyCAM FC offers the ability to perform reimbursable procedures of fundus
photography, enable an ophthalmologist or optometrist to visualize glaucoma pathophysiology, and conduct
research on development of OBF-based biomarkers for ophthalmic and systemic pathology with symptoms in
the ocular vasculature.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The goal of our project is to demonstrate the feasibility and usefulness of utilizing ocular blood flow metrics for clinically relevant insights on glaucoma status by conducting a clinical study. This project will also support us in commercializing an enhanced fundus camera that can visualize color fundus photos in stereo-mode as well as dynamic ocular blood flow information for use in the glaucoma clinic and general ophthalmology and optometry settings.